Michigan Nutrition Obesity Research Center

Abstract/Summary – Admin Core
The Administrative Core will be responsible for the overall management of the MNORC, its
Cores and the Weight Management Program. The MNORC will continue to set goals and
objectives for the Center’s operation and conduct ongoing review of the Center through
consultation and survey of the Center’s membership, advice of Internal and External Advisory
Committees and interactions with other P30 and external NORCs. The Administrative Core will
oversee the resource expenditures of the MNORC and be responsible for required reporting to
internal and external stakeholders as well as NIDDK staff.
The MNORC Administrative Core, through the Core’s Working Group, will oversee all
Enrichment Program and the Pilot and Feasibility Grant Program, ensuring that expenditure of
cost-share funds are properly allocated to support investigators. The Core will also ensure that
agreements between the administrative entities who have agreed to co-funding will be properly
executed and documented. The Administrative Core will oversee content for a Website for
investigators and the public use to interact and to promote MNORC activities. Finally, the
Administrative Core will be the conduit for the interactions of the MNORC with the research
community at the University of Michigan and be responsive to the needs of the Research Base.
It will be the responsibility of the Administrative Core to encourage researchers to become new
members of the MNORC Research Base and to encourage interactions among the research
community at UM with interests in obesity and/or nutrition research.